URSODEOXYCHOLIC ACID/CYSTIC FIBROSIS ASSOCIATED LIVER DISEASE

The purpose of the project is to determine the safety and efficacy of ursodeoxycholic acid for the treatment of cystic fibrosis associated liver disease.